Building a Substance Use Data Commons for Public Health Informatics

PROJECT SUMMARY Substance misuse comprises a complex set of conditions, often associated with comorbidities and social factors, that are the root cause of misuse and can lead to poor outcomes. Opioid misuse, non-opioid illicit use, and alcohol misuse can also lead to repeated encounters with hospital emergency departments or first-responders. Although substance use disorders are a leading cause of repeat hospital visits, our fragmented data systems do not generate comprehensive information on the scope and character of this poorly treated condition that would allow providers to improve and monitor the quality of care. Crucial social and behavioral determinants strongly linked with substance use (e.g., pre-hospital behavioral events) are not readily available to health systems, but they are important data that can be used to better train artificial intelligence/machine learning (AI/ML) models. In principle, hospitals are well-positioned to address these challenges. In practice, these opportunities are frequently missed given the fragmented structure and design of current data systems. Many patients living with substance misuse visit a specific hospital for the first time after an overdose or a related medical condition of drug use such as infection or trauma. Substance use-related conditions are among the top reasons for repeat visits to the hospital. This supplemental will expand on the existing work of the Parent R01, which is focused in clinical informatics, and build an AI/ML-ready public health informatics Substance Use Data Commons and share a novel, all-inclusive prediction model that will help guide clinical interventions and regional health policy. We aim to foster an academic-public-private collaboration to build a data ecosystem in this supplemental grant that will harmonize data across a Wisconsin regional hospital, pre-hospital agencies like fire, and public health agencies for the first time. We will build a cohort with substance misuse with linked data that are engineered as an AI/ML-ready data commons. During our one-year timeline, we will train and test an AI/ML model that can prioritize those at the highest risk for poor outcomes and uncover important biases in our data sources with input by health equity experts. The following goals are to be accomplished from the supplement proposal: (1) build a Substance Misuse Data Commons across a major hospital system and Wisconsin agencies; (2) develop and validate a machine learning tool for substance use-related health outcomes; and (3) examine model performance across health disparate groups (race/ethnic groups as well as neighborhoods). Access to combined data from hospitals, public health agencies, and first responder agencies could provide a comprehensive data resource that would allow us to reliably identify, risk stratify, and prioritize care for some of Wisconsin's most vulnerable residents through AI/ML modeling.

Public health relevance
PROJECT NARRATIVE This proposal aims to establish a comprehensive Substance Use Data Commons that combines health system data with public health agency data for a platform designed for machine learning activities to provide health system and public policy leaders guidance on clinical interventions and regional health policy change. We anticipate that the research proposed will surface important biases and lead to novel tools in artificial intelligence that leverage both the electronic health records (EHR) and pre-hospital data from the Wisconsin Department of Health Services and Emergency Medical Services. Ultimately, the tools developed from this proposal will be used to address NIH's special research interest (NOT-OD-21-094) to support collaborations that bring together expertise in biomedicine, data management, and artificial intelligence and machine learning (AI/ML) to make NIH-supported data useful and usable for AI/ML analytics